Targeting Oncogenic KRAS with Brush-Architectured Poly(ethylene glycol)-DNA Conjugates

Project Summary/Abstract
Mutant forms of KRAS are a key driver in human tumors but remains refractory to therapeutic intervention
despite over three decades of research. Clinical attempts to directly or indirectly inhibit KRAS function have
both yielded unsatisfactory results. The difficulty for developing small molecule KRAS inhibitors has heightened
the importance of alternative methods targeting the oncogene. One such strategy involves therapeutic nucleic
acids, which make it possible to deplete target proteins that are intractable to conventional drug modalities. We
have developed a novel form of nucleic acid therapeutics, termed pacDNA, that substantially enhances the
antitumor activity of nucleic acid drugs by elevating in vivo stability, accelerating cellular uptake, and improving
plasma pharmacokinetics and tumor accumulation, allowing a much lower dosage to be used compared to
conventional methods. The pacDNA also suppresses nearly all side effects associated with traditional nucleic
acid drugs by reducing unwanted nucleic acid-protein interactions. In this proposal, we aim to build upon our
promising preliminary results, and gain deeper insights into the cell biology of the pacDNA with respect to cell
uptake mechanism, intracellular trafficking, KRAS depletion and subsequent cell signaling, and demonstrate
efficacy in KRAS-dependent non-small cell lung cancer cell lines and 3D models. In addition, we will study the
primary pharmacology and antitumor activity of pacDNA in advanced preclinical lung cancer models including
an orthotopic tumor model, a patient derived tumor model, and a syngeneic genetically engineered mouse
model (GEMM), and perform initial in vivo safety and tolerability studies. The outcome of this project will be a
safe and potent anti-KRAS agent that can be readily translated into clinical studies for non-small cell lung
cancer and potentially additional cancer classes.

Public health relevance
Project Narrative Mutated KRAS is a highly prevalent oncoprotein driving a number of cancers, including forms of lung, pancreatic, and colorectal cancers, but it has not been successfully inhibited using traditional pharmacological approaches despite over thirty years of research. Here, we propose a DNA-based therapeutic agent, which works by preventing the mutated KRAS from being produced in the first place. Although preliminary data already suggest the effectiveness of this agent in a mouse model, we aim to gain a deeper understanding about its cell biology and more confidence regarding its efficacy in advanced preclinical models through this proposal, with the goal of translating it into the clinic.